Advanced Genotypic and Phenotypic monitoring of Drug Resistant TB to Improve TB Treatment Outcomes

Project Summary
This project utilizes translational approaches to use novel assays to understand the emergence of resistance to
drugs to treat Mycobacterium tuberculosis (Mtb), the causative agent of tuberculosis (TB). Drug-resistant TB
incidence has increased 80% worldwide over the past 15 years with high mortality, prolonged treatment course,
and poor outcomes. Global multi-drug resistant TB (MDR-TB) cure rates average 65% and as many as 11% of
MDR-TB patients develop amplification of drug-resistance on treatment. While emergent drug-resistance is a
major challenge it is often detected too late. This application will study pairs of Mtb strains from patients that had
drug-susceptible TB at baseline then developed drug-resistant TB. There is extensive clinical and adherence
data for these patients. Functional assays for drug-resistance mechanisms will be done to better understand
development of drug-resistance under treatment.

Public health relevance
PROJECT NARRATIVE Project Narrative Tuberculosis (TB) is the leading cause of death worldwide among people living with HIV/AIDS, and drug-resistant TB HIV is increasing in South Africa. Medication adherence and retention in care are critical components of the care continuum and predict TB cure and survival. This proposal seeks to understand local barriers and determinants for adherence and retention in South Africa, implement an innovative community-based intervention, and evaluate the effect of the intervention on clinical outcomes and patient barriers to adherence and retention.